Targeting the oncoprotein that drives FLC

Project Summary / Abstract
Fibrolamellar hepatocellular carcinoma (FLC) is a usually lethal primary tumor in children, adolescents and
young adults. The primary tumor is initiated and driven by a single alteration in the DNA: A deletion of ~400kb
that results in a fusion gene between the heat shock co-chaperone DNAJB1 and the catalytic subunit of protein
kinase A, PRKACA. If the tumor is limited to the liver, then surgery is the accepted therapy. However, if the
tumor has metastasized, there is no accepted therapy. Project 4 will develop therapeutics targeted to the
fusion oncoprotein. It will use therapeutics to block the kinase activity of the oncoprotein and therapeutics to
target the oncoprotein to the proteasome for destruction. The therapeutics will be tested on isolated protein, in
dissociated cells from patient-derived xenografts, in human liver organoids of FLC and in mice with patient
derived xenografts and in genetically engineered mouse models.